Investigating the role of NGN3 in Notch signaling repression during pancreatic endocrinogenesis

ABSTRACT
Type 2 diabetes is a chronic condition characterized by abnormally high blood sugar levels that can result in
stroke, kidney failure, and limb amputation. Dysfunction of pancreatic insulin-producing beta cells is a factor in
the pathogenesis of diabetes. Transplantation of stem-cell derived beta cells represents a promising cellular
therapy for patients with diabetes; however current protocols generate immature cells because they do not fully
recapitulate the early molecular processes of human beta cell development. Our lab’s recent studies have
demonstrated that cells lacking a functional NGN3 protein do not fully mature into PDX1+/ NKX6.1+ pancreatic
progenitors capable of differentiating into all pancreatic lineages, implying that NGN3 has a critical role in
facilitating early-stage human pancreatic development. To understand the role of NGN3 in early
pancreatogenesis, I have performed combinatorial single cell transcriptome and chromatin analyses of
functionally-null patient-specific induced pluripotent stem cell lines to interrogate the genetic and epigenetic
landscape of pancreatic progenitor cells in the presence and absence of functional NGN3. Cell-cell interaction
analysis indicated Notch signaling interactions between maturing pancreatic progenitors and other cell subtypes
were stronger in the absence of functional NGN3. Notch signaling is known to regulate angiogenesis in the
pancreas, and my data determined that pro-angiogenic factors are upregulated at the pancreatic progenitor stage.
This preliminary data suggests that NGN3 has a previously unidentified role in inhibiting Notch signaling to
facilitate progenitor cell maturation. I hypothesize that NGN3 represses Notch signaling to promote pancreatic
progenitor cell maturation. This proposal will use differentiation assays, co-culture systems, and chromatin
immunoprecipitation assays to: 1) determine if inhibition of NOTCH2/3 receptor signaling facilitates pancreatic
progenitor cell maturation in the absence of NGN3 and 2) determine if NGN3 directly activates the expression of
the endogenous Notch inhibitor NUMB. This set of experiments challenges the prevailing paradigm that NGN3
acts solely as a coordinator of endocrine-specific gene expression and may elucidate a novel role for it as
facilitator of early pancreatic progenitor maturation.
This fellowship training plan includes hands-on training in single cell analysis, molecular biology, and
developmental biology. I will participate in seminars on cutting-edge research, scientific writing, and career
development, and will present at national and international conferences. Children’s Hospital Los Angeles
partners with the University of Southern California to be a premier teaching hospital. It provides state-of-the-art
facilities, core services, and workshops through which I will be mentored by experts in their fields and can mentor
numerous students. Overall, this training plan and supportive environment will equip me with the critical thinking
and technical abilities needed to become a leading researcher in developmental biology and translational
research.

Public health relevance
PROJECT NARRATIVE Diabetes is a disease of the endocrine pancreas that affects over 37 million people in the United States. The field’s lack of understanding of early human endocrine developmental processes hinders efforts to find a cure. This proposal aims to investigate the key mechanisms that establish the transition to endocrine differentiation during pancreatic organogenesis, therefore allowing us to improve on existing strategies for diabetes management as well as discover novel therapies.